FITTING TWO COMPONENT SPECTRA USING NLSL PROGRAM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. NLSL is a non linear least squares program for fitting CW spectra based on microscopically order but macroscopically disorder (MOMD) model. A service request was received from Dr Gary Gerfen on fitting two component spectra using the NLSL program from ACERT website. A hand on instruction was given on the procedure of generating correct fitting results from the seed parameters.